Understanding Oral Anticancer Medication Adherence among Patients with Multiple Myeloma

PROJECT SUMMARY
This K23 application support's the applicant's long-term goal to build an independent, sustained program of
research leading patient-oriented research studies focused on improving medication adherence and health
outcomes among socioeconomically diverse patients with cancer. Cancer treatment advances, including
costly, long-term therapy with oral anticancer medication, have extended survival for patients with cancer,
including those with multiple myeloma, a life-threatening blood cancer associated with significant pain and
reduced quality of life. Improved knowledge of how oral anticancer medication adherence influences patient
health outcomes over time and how financial hardship may affect these relationships will inform future large-
scale studies aimed at developing timely, targeted interventions to improve adherence, reduce pain, and
improve quality of life in patients with cancer. This career development award will support the applicant's
training and research goals through focused, expert mentorship, coursework, and other training activities
designed to 1) develop theoretical and measurement knowledge specific to medication adherence research; 2)
develop statistical and qualitative methods expertise needed to conduct longitudinal, mixed method research;
and 3) gain in-depth knowledge and research skills to conduct culturally-sensitive research with vulnerable
populations. The proposed research project will generate knowledge about temporal relationships among
adherence, financial hardship, pain, and quality of life in patients initiating long-term oral anticancer medication
for multiple myeloma. Utilizing a longitudinal, mixed method design in a sample of 90 socioeconomically
diverse patients newly prescribed oral anticancer maintenance therapy for multiple myeloma with repeated
measure assessment at baseline, 3-months, and 6-months post therapy initiation, the study aims to 1)
prospectively determine the influence of oral anticancer medication adherence on pain and quality of life; 2)
determine whether financial hardship moderates the relationship between oral anticancer medication
adherence and pain and quality of life over time; and 3) explore the patient experience of taking oral anticancer
medication using qualitative methods in a subset of participants with differing adherence patterns. Descriptive
statistics, mixed-effects modeling, and lagged value effects using Markov modeling will be used to achieve
aims 1 and 2, respectively. Qualitative description and content analysis will be used to achieve aim 3. This
proposal directly aligns with the National Institute of Nursing Research's mission to understand the behavioral
aspects of symptoms to improve health outcomes and quality of life. Emory University's research environment
provides strong resources that will facilitate Dr. Belcher's career development into an independent research
scientist.

Public health relevance
PROJECT NARRATIVE Patients with multiple myeloma, a life-threatening blood cancer, frequently experience pain and reduced quality of life. More recently, cancer treatment for these patients includes taking expensive pills on a long-term basis to control their cancer, but it is unclear how medication adherence influences pain and quality of life. This study tests how medication adherence impacts pain and quality of life over time, and how financial hardship experienced due to cost of cancer care may influence how patients do or do not take these medications.